Modeling the public health impact of a national menthol cigarette ban.

PROJECT SUMMARY/ABSTRACT
Smoking is the leading cause of preventable disease and death in the United States. More than one-third of
smokers in the United States use menthol cigarettes. Menthol cigarettes are of particular public health concern
because they make it easier for adolescents to initiate smoking and are more difficult to quit than non-menthol
cigarettes. In addition, menthol cigarettes are disproportionately used by youth, low-income and racial/ethnic
minority smokers. In 2011 the Tobacco Products Scientific Advisory Committee (TPSAC), a Congressionally
mandated committee assembled to advise the Food and Drug Administration (FDA), reported that “removal of
menthol cigarettes from the marketplace would benefit public health in the United States.” Despite TPSAC’s
conclusion, the FDA has not banned menthol cigarettes. Instead, the FDA has requested additional research to
inform regulatory action. The objective of this project is to use microsimulation modeling to estimate the
impact of a national menthol cigarette ban on tobacco use and tobacco-related disease, specifically
cardiovascular disease (CVD) and tobacco-related cancers. This research would inform potential FDA
regulatory action on menthol cigarettes. The project has three aims. Aim 1 identifies trajectories of cigarette
use over time using longitudinal, nationally representative survey data. To achieve this aim, I will use Markov
chains to compute transition probabilities of tobacco use behavior (frequency, intensity, flavor preference) over
time. Aim 2 systematically reviews and meta-analyzes studies examining the effects of menthol cigarette bans
on tobacco product use. This will be the first review to synthesize the literature on the impact of a menthol
cigarette ban, providing critical information for microsimulation modeling. Aim 3 builds a microsimulation model
of smoking and tobacco-related disease to estimate the impact of a national menthol cigarette ban on smoking,
CVD, and tobacco-related cancers. I will establish parameters for the model using the best epidemiological
evidence and conduct sensitivity analyses to test the validity of the model. Finally, I will estimate the change in
smoking, CVD, and tobacco-related cancers that would occur in the total population and in specific
socioeconomic and racial/ethnic groups if a menthol cigarette ban were implemented. I hypothesize that a
national menthol cigarette ban will reduce socioeconomic and racial/ethnic disparities in smoking, CVD, and
tobacco-related cancers. The career development award will help me achieve my goal of becoming an
independent tobacco control and health disparities researcher. I will receive the training and mentorship
needed to build an independent research program focused on the role tobacco control policy may play in
improving the public’s health, in particular among groups that disproportionately suffer from smoking and
tobacco-related disease. This award will culminate in an application for an R01 grant to expand upon my
microsimulation model, comparing the impacts of additional tobacco control policies on smoking and disease.

Public health relevance
PROJECT NARRATIVE More than one-third of smokers in the United States use menthol cigarettes. The Food and Drug Administration is considering regulating menthol cigarettes, including removing menthol cigarettes from the marketplace, and has requested research to inform regulatory action. This project uses microsimulation modeling to estimate the impact of a national menthol cigarette ban on smoking, cardiovascular disease and tobacco-related cancers.